Impact of Integrated HIV/NCD Screening on HIV Testing Uptake and Engagement in HIV Care: An RCT in Kisarawe, Tanzaniz

PROJECT SUMMARY / ABSTRACT Abstract: The AIMS of the parent grant for this supplement have not changed. Due to impacts of COVID-19 we were unable to collect the clinical data from the HIV ART clinics. These impacts included being restricted from entering the ART clinics to extract participant clinical data, as well as an outbreak of COVID-19 among our study staff that lead to a large number of illnesses and associated quarantines that stopped field activities. In addition, one of our lead coordinators died of COVID, and another was hospitalized in dire condition for an extended time. These data are needed to establish our primary outcome for AIM 3, which is to establish whether retention in HIV care among newly enrolled clients is enhanced over 24-months with the addition of NCD care. We now have clearance to return to the ART clinics to collect these data.

Public health relevance
PROJECT NARRATIVE The US Government is the leading funder of HIV prevention and care in low- and middle-income countries, and there is a need to allocate resources with evidence-based strategies proven to work in the most efficient manner possible. This supplement is designed to support the completion of the parent grant. The COVID-19 pandemic caused a severe disruption in our ability to collect critical clinical data on study participants in Tanzania. The supplement will provide essential support to allow us to complete this data collection.